IND-enabling Preclinical Studies for Aβ and Dual Aβ/Tau MultiTEP platform-based AD Vaccines

Project Summary Immunotherapy is still considered a very promising therapeutic strategy for AD prevention when certain conditions are met. Data from various immunotherapeutic studies support our long- standing tenet that immunogenic AD vaccines could at least delay disease progression when they target both Aβ and Tau pathological molecules at an early stage of the disease before AD manifestation. It is impractical to use very expensive mAbs as a preventive treatment of healthy subjects due to the need for frequent (monthly) administration of high concentrations (700-800mg per IV injection) of this immunotherapeutic. In contrast, almost all effective vaccines are effective when they are used as a preventive treatment. Accordingly, we are seeking a revision to U01 AG060965 that will support a submission of INDs to the FDA for future clinical trials that will allow us to sequentially or concurrently treat early AD subjects with extremely immunogenic Aβ and tau vaccines based on the same and very immunogenic MultiTEP platform and novel adjuvant AdvaxCpG. Our proprietary vaccine platform can stimulate adaptive immunity, providing broad coverage of human MHC polymorphisms and activating both naive Th cells and pre-existing memory Th cells generated in response to conventional vaccines and/or infections with various pathogens during one's lifespan without the activation of harmful autoreactive T cells. These non-self Th cells should activate B cells and induce the production of therapeutically potent antibodies specific to pathological Aβ and Tau in humans similar to that we observed in inbred WT and Tg mice as well as outbred rabbits and monkeys. If safe and immunogenic in Phase 1 trials, the AV-1959R/A vaccine could be used as a preventive measure in healthy people at risk of MCI (based on biomarkers) and later used to vaccinate MCI people with the AV-1980R/A vaccine or their combination to delay AD.

Public health relevance
Project Narrative In the scope of the parental U01 AG060965 project, we have manufactured and are currently conducting IND- enabling safety/toxicology studies on cGMP adjuvanted anti-Tau vaccine, AV-1980R/A, while the main goal of this revision proposal is to complete IND-enabling safety/toxicology studies on anti-Aβ AV-1959R/A and AV- 1959R/A+AV-1980R/A dual vaccine formulations. Upon completion of these two projects, our multidisciplinary team can obtain three INDs; one for AV-1980R (original project), the second for AV-1959R (revision), and the third for the combination of the two two vaccines. Having these three INDs with two vaccines composed of the same MultiTEP platform will allow us to initiate dual vaccination in people with very early AD and if successful, start preventive vaccination of healthy people with AV-1959R+AdvaxCpG (AV-1959R/A anti-Aβ vaccine) in order to delay Aβ aggregation and downstream pathological processes (e.g., tau accumulation and inflammation) and continue treatment with AV-1980R+AdvaxCpG (AV-1980R/A tau vaccine) in order to inhibit/reduce tau pathologies and AD progression.